Infrastructure Support for Prevention Research Centers' Cacer Prevention & Control Network

The CPCRN is a multi-site network established to work with communities in responding to a broad spectrum of issues related to cancer prevention and control. As a collaborative venture, the CPCRN is expected to work for the good of public health nationally beyond what one center alone might achieve.